TR&D1: Ultra-Fast Multiparametric MR Imaging Methods for Quantitative PET/MR

Combining quantitative MR (qMR) with PET synergistically provides perfectly registered,
complementary physiological biomarkers. Our pioneering work during the initial funding cycle, Y1-4,
of our P41 in quantitative PET/MR, has provided solutions to some of the most vexing problems
affecting PET/MR, including reliable and accurate corrections for attenuation correction and
involuntary subject motion. These techniques achieve PET resolution close to the intrinsic resolution
of the scanner and enable a range of novel PET/MR applications. In this renewal application, we will
develop and deliver unique PET/MR imaging technologies that not only enable physiological high-
impact novel PET/MR but will also benefit standalone MR research. We focus our efforts on multi-
parametric qMR techniques by leveraging our recent breakthroughs on subspace/manifold modeling,
MR-physics informed deep learning (DL), and multi-contrast ultra-fast MR sequences. Our proposed
research focuses on developing and delivering new PET/MR imaging techniques along three axes: i)
multi-parametric, free-running, cardiac MRI method for motion corrected whole-heart membrane
potential imaging using PET/MR; ii) high resolution MRSI for multi-modality, multi-parametric,
molecular imaging using PET/MR; and iii) ultra-fast, multi-component quantitative MR using deep
learning and MR physics modeling. We will validate the proposed methods in TR&D3 PET/MR axes
of research and through collaborations with our Collaborative Projects. We will leverage the DL
methodologies proposed in TR&D2 to further improve image quality of quantitative PET/MR
techniques in TR&D1.